Integrating biomechanical and biochemical signaling in lacrimal gland development

PROJECT SUMMARY
The long-term objective of this project is to investigate the signaling mechanisms governing lacrimal gland
development, which has important implications for understanding the etiology of diseased lacrimal glands in
humans. The lacrimal gland, a complex organ comprising acinar, myoepithelial, and duct cells, presents a
unique model for studying cellular interactions. Despite its importance, the signaling pathways among these
cell types remain poorly understood. Central to our investigation is the hypothesis that adherens junctions
regulate the Hippo-Yap pathway, which in turn modulates Notch signaling during lacrimal gland development.
Using conditional mutant mouse models, we will examine the role of cadherins in restraining Yap activity and
promoting acinar cell genesis. We will employ multiomic analysis to elucidate the genetic and epigenetic
regulatory networks controlled by Yap in the lacrimal gland. Lastly, we will investigate the intersection between
Yap and Notch signaling pathways in acinar cell maturation. By deciphering the intricate interplay of
biomechanical and biochemical signals, this project holds the potential to unveil novel therapeutic targets for
human lacrimal gland dysfunction and dry eye disease. This could lead to the development of innovative
treatments, offering significant relief to millions of patients.

Public health relevance
PROJECT NARRATIVE This project investigates the mechanism of biomechanical and biochemical signaling in lacrimal gland development. It is expected to contribute to our understanding of signaling pathways in human development and disease, and it will inform the development of future clinical interventions for treating dry eye disease.